Epidemiological, Geospatial, and Phylogenetic Evidence to Inform Interventions Against HIV Transmission during Acute and Early HIV Infection in Lilongwe, Malawi

PROJECT ABSTRACT
The first few months of HIV infection, broadly referred to as “early HIV infection,” are characterized by elevated
viral loads and increased per-virion infectivity, resulting in higher transmission rates compared to the
subsequent chronic infection period. Modeling studies have estimated that transmission during early infection
disproportionately contributes to population-level HIV incidence: members of our team estimated that HIV
transmission during the first five months of infection accounted for 38% of incident infections in 2010 in
Lilongwe, Malawi, while a recent model from eSwatini estimated that transmission during the first three months
of infection accounted for 15% of incident infections. Both studies concluded that to end the HIV epidemic,
transmission during early infection must be addressed. The pre-seroconversion or “acute” phase, which
represents the first several weeks of early infection, is characterized by the highest viral loads and infectivity.
Detection of acute HIV infection (AHI) requires RNA or antigen testing, which is difficult to implement in many
settings. Members of this study team have shown that sexually transmitted infections (STI) clinics are
consistently high-yield settings for AHI detection and that an intervention (iKnow - NCT02467439) integrating
AHI screening, assisted partner notification, and social contact referral in STI clinics can efficiently identify
undiagnosed cases of HIV. The iKnow team assembled one of the largest documented cohorts of persons with
AHI in Africa (n=115) between 2015 and 2019 at Bwaila STI clinic in Lilongwe, Malawi. Using questionnaire,
household GPS, and phylogenetic data from the iKnow study, the proposed project will examine the prevention
potential of AHI-focused interventions that are anchored in STI clinics and supplemented by geographically-
and demographically-guided interventions in communities. Specifically, we will: 1) investigate the
characteristics of persons and places associated with AHI; 2) test for spatiotemporal clustering of AHI cases
and determine whether spatiotemporal AHI clusters were formed through phylogenetically linked transmission
events; and 3) model the population-level impact on HIV incidence of interventions focusing on acute and early
HIV infection. These analyses will provide novel insights into HIV transmission dynamics and inform
interventions against transmission during acute and early HIV infection. To support the completion of this
project and the applicant’s development into an independent investigator, the proposed training plan includes
close mentorship by global experts in phylogenetics, phylogeography, mathematical modeling, and HIV
prevention, as well as external coursework and readings. The applicant will develop scientific communication
skills through manuscript writing and presentations to the PANGEA HIV consortium.

Public health relevance
PROJECT NARRATIVE The first few months of HIV infection are characterized by elevated infectiousness, resulting in a disproportionate contribution to population-level HIV spread. This project aims to increase understanding of epidemiological, spatial, and phylogenetic aspects of HIV transmission during early HIV infection, and to estimate the population-level impact of tailored interventions against transmission during this period. Findings will inform future HIV prevention strategies that recognize the importance of addressing early HIV infection in efforts to end the HIV epidemic.